Roles and regulations of APE1 in ATR signaling

Project Summary/Abstract
Genome of all cells are constantly exposed to endogenous insults such as reactive oxygen species and
environmental toxins, leading to different types of DNA damage such as Apurinic/apyrimidinic (AP) sites,
single-strand breaks (SSBs), and single-strand DNA (ssDNA) gaps. Although a good progress has been
made on how a global ATR-mediated checkpoint signaling is triggered by DNA damage, it remains elusive
how the ATR signaling is activated by ssDNA gaps derived from DNA damage and replication stress, and
in the nucleoli where the RNA polymerase I-mediated rRNA transcription and ribosome assembly take
place. Whereas multifunctional protein APE1 has been involved in base excision repair, redox regulation,
and RNA processing, it remains unclear how APE1 plays critical functions in nucleolar ATR signaling and
how APE1 recognizes and senses ssDNA gaps for the activation of ATR signaling. Our substantial
preliminary data suggest that APE1 assembles into distinct liquid-liquid phase separation (LLPS) in vitro
and in the nucleoli of cultured cancer cells but not normal cells to promote the ATR-Chk1 signaling, leading
to compromised ribosomal RNA transcription and reduced cell viability. Furthermore, APE1 plays a direct
role in the recognition and association of ssDNA gaps to recruit the ATR/ATRIP complex in in vitro
reconstitution system and to promote the ATR checkpoint signaling in Xenopus egg extracts. Our central
hypothesis in this project is that APE1 forms LLPS in vitro and in the nucleoli to promote the ATR
checkpoint signaling and that APE1 directly recognizes ssDNA gaps for the recruitment and activation of
ATR/ATRIP complex. We will elucidate the distinct regulatory mechanisms of APE1 in ATR signaling via
two Specific Aims: (1) to determine the mechanisms of how APE1 forms liquid-liquid phase separation in
vitro and in nucleoli to sense pH in cancer cells but not normal cells and promotes the nucleolar ATR-Chk1
checkpoint signaling to regulate rDNA transcription and sensitivity to chemotherapy drugs, and (2) to
determine how APE1 directly associates with ssDNA gaps to promote the global ATR-Chk1 signaling in
oxidative stress and DNA replication stress in Xenopus egg extracts and mammalian cells. We will test our
major hypothesis regarding distinct mechanisms of APE1 in ATR DDR signaling using cutting-edge
molecular biology, cell biology, and biochemical approaches in in vitro reconstitution systems with purified
proteins, Xenopus egg extracts, and cultured mammalian cells. Anticipated results from this project will
make a paradigm shift on how APE1 regulates ATR checkpoint signaling in the nucleoli and how APE1
recognizes and senses ssDNA gaps for the activation of the global ATR-Chk1 signaling to maintain
genome stability. This work will provide novel insights into new strategies for cancer therapy such as
modulating the distinct regulatory mechanisms of APE1 in ATR signaling in cancer cells.

Public health relevance
Project Narrative This project investigates how genome stability is maintained differently by ATR signaling pathway in cancer cells and normal cells. Our better understanding in DNA repair and genome stability can help to provide new treatment options for cancers.